Predoctoral Training Grant in Basic Neuroscience

DESCRIPTION (provided by applicant): This application requests funds to continue our integrated basic neuroscience training program at the University of Pittsburgh and Carnegie Mellon University. This training grant (T32 NS07433), currently in its ninth year of funding, has been successful in recruiting and training high quality predoctoral students in neuroscience. Funds are requested to support eight first and second year graduate students in the Center for Neuroscience at the University of Pittsburgh and the Center for the Neural Basis of Cognition, which is a joint center of the University of Pittsburgh and Carnegie Mellon University, with support being provided to the top quarter of our trainees. The program described in this application focuses primarily on research training in the laboratories of a large and diverse neuroscience training faculty. Students begin laboratory research immediately upon entering the program, and do two or three semester-long laboratory research rotations in their first year. The training faculty, consisting of 73 faculty from the University of Pittsburgh and Carnegie Mellon University, provides expertise in neuroscience ranging from cellular and molecular to developmental to systems and cognition, and students are exposed to this breadth of neuroscience. In addition to research, students take a series of two intensive one-term core courses in basic neuroscience, at least three elective courses, a course in statistics, and a variety of seminars and journal clubs. Trainees also participate in a series of professional development workshops that provide explicit training in such survival skills as written and oral communication, obtaining jobs and grants, teaching, and managing a research lab. Training in the responsible scientific conduct is an integral part of the professional development workshops, the core curriculum, and laboratory training. A solid structure is in place to mentor the trainees and monitor their progress through the program. Students pass through a series of milestones, including the first-year Reprint Exam, a second-year research evaluation, and a grant proposal-based comprehensive exam in the third year, prior to submitting a thesis proposal and progressing to full-time thesis research. Each student has an advising committee to see them through these milestones and assist with their mentoring. Data are presented to document that we recruit outstanding trainees and provide them with excellent training.